Brain biomarkers of late talking: A longitudinal study of early identification and risk of persistence

PROJECT SUMMARY/ABSTRACT
Children typically have a vocabulary of 150-450 words by 2 years old. However, ~15% of children exhibit
expressive language delays, which is referred to as late talking. Late talking can be a precursor to
neurodevelopmental disorders, such as developmental language disorder, developmental dyslexia, or autism
spectrum disorder, and comes with long-term educational and social consequences. However, not all children
who are late talkers experience persistent delays, with some late talkers recovering by early childhood; these
children are referred to as transient late talkers. It is difficult to prospectively know which late talkers will persist
into future delays, thus studies of the etiology of late talking and persistent language delays are needed.
Neuroimaging studies have identified differences in brain structure and function between late talkers and their
non-late talking peers. However, these neural differences have only been studied after late talking is
diagnosed, thus there is a critical need to prospectively identify late talkers by examining early neural
development before observable behavioral differences manifest. Taken together, the current proposal seeks to
address this need by prospectively identifying biomarkers of late talking before diagnosis and examining
biomarkers that can separate transient late talkers from those who persist into future delays.
This proposal aims to address this need by leveraging a large, rich, longitudinal, pediatric neuroimaging
dataset collected from over 700 children, the Early Brain Development Study. The proposed study will use
measures of structural and functional brain development from 0-2 years of age and measures of expressive
language at ages 2 and 6 years to examine biomarkers of late talking and future delays. Cutting edge graph
theoretical techniques will be used to estimate functional connectivity of the language and subcortical networks
at rest. Trajectories of structure (Aim 1a) and functional connectivity (Aim 1b) of the language network will be
estimated across ages 0-2 years. These trajectories will be tested as early life biomarkers that can predict
language delays at 2 years. In Aim 2 a hierarchical clustering algorithm will be used to identify brain-based
subgroups of children who meet criteria for late talking at age 2. These subgroups will be examined for
differences in verbal language skills at age 6 years to test whether biomarkers that parse heterogeneity in late
talkers at age 2 years predict persistence, or alternatively transience, of language delays. The findings from
this proposal stand to inform our understanding of the underlying biological mechanisms and developmental
pathways of late talking, prior to diagnosis, allowing for timely identification of children at risk of language
delays, resulting in better outcomes for these children. In accordance with the goals of the funding mechanism,
all data derivatives used for the proposed studies will be curated on Open Science Framework to create a
novel shared resource for studying late talking.

Public health relevance
PROJECT NARRATIVE Despite a clear link between late talking and risk of later language delays and disorders, including Developmental Language Disorder, the field still lacks an understanding of early predictors of late talking and risk factors that result in some late talkers experiencing persistent language delays. The proposed research will leverage a large, longitudinal, existing dataset to identify biomarkers of late talking by exploring trajectories of brain development prior to diagnosis (birth to age 2; Aim 1a and Aim 1b) and by parsing heterogeneous structural and functional brain features that may delineate between late talkers who experience persistent versus transient delays (Aim 2). Biomarkers identified in the current study stand to inform early identification, personalized intervention, and our understanding of heterogeneity in language development and disorders.